Platelet Derived Beta-2 Microglobulin Regulates Monocyte Homeostasis

Project Summary Platelets are the cellular mediators of thrombosis, but they also have central roles in immune responses. Stimulated platelets release many soluble immune mediators that recruit and activate white blood cells. Beta-2 microglobulin (β2M) is a chaperone molecule essential for MHCI trafficking and stability. Platelets contain abundant β2M that is released upon activation into the extracellular environment. Elevated plasma β2M is associated with increased risk for inflammatory diseases, including cardiac events, and previous reports suggested it has direct signaling effects on monocytes. Through preliminary studies we have shown that β2M directly promotes a pro-inflammatory response in monocytes. We have generated unique platelet specific β2M-/- (Plt-β2M-/-) mice that we will use with a MI model to determine the mechanisms of β2M regulated monocyte responses and their effect on inflammation and fibrosis. Using this novel mouse model, we have discovered that platelets are the major source of plasma β2M and that it is significantly elevated post- myocardial infarction (MI). Work from our lab has shown that platelet-derived β2M is critical to a pro- inflammatory (Ly6CHi) monocyte response post-MI. This lead us to hypothesize that platelet derived β2M is a novel regulator of monocyte response to MI. To pursue this hypothesis, I propose the following Aims: 1) To demonstrate mechanisms of platelet mediated monocyte inflammatory phenotype, 2) To demonstrate how platelet-derived β2M mediates monocyte responses and outcomes in an ischemic myocardial injury model. We will perform studies using primary mouse and human monocytes as well as a human monocytic cell-line (THP-1) to demonstrate the signaling mechanisms of β2M related monocyte polarization. Monocyte phenotype will be characterized by surface markers using flow cytometry and cytokines using ELISA. We will determine the mechanism of β2M-induced monocyte activation through use of surface plasmon resonance and receptor and signal transduction inhibitors, confirmed by immunoblot. Heart function and MI responses in our WT and Plt-β2M-/- mice will be analyzed using echocardiogram and histology. Plasma will be collected to determine the cytokine profile of our mouse models. Hearts will be collected for qRT-PCR and single cell isolation to phenotype the macrophages and fibrotic responses to MI. These data will define novel non-chaperone, direct inflammatory roles for β2M in monocyte and subsequent macrophage responses to MI.

Public health relevance
Project Narrative Due to modern treatments, the number of people who suffer heart attacks has steadily declined; however, the number of people who suffer heart failure after a heart attack has risen. This conflicting phenomenon highlights the need to understand novel mechanisms of heart repair after a heart attack for potential therapeutic targets. Our group intends to understand a unique way that platelets help white blood cells participate in the healing of the heart after a heart attack.